Receptor-mediated clearance of synaptic tau as a novel therapy for Alzheimer's disease.

Tau-containing neuronal inclusions are a prominent feature of Alzheimer’s disease (AD) and other disorders with
tauopathy, implying a deficit in the cell’s ability to clear misfolded tau species either as a cause or a consequence
of the disease process. Tau is a substrate of the ubiquitin proteasome system (UPS), thus elucidating a
mechanism for how proteasome becomes dysfunctional in tauopathy may identify pathways that could be
targeted therapeutically to halt disease progression. We have recently provided insight into a direct, negative
effect of aggregated and oligomeric tau on proteasome function using in vivo and in vitro models. Additionally,
we have shown that pharmacological activation of proteasome function by phosphorylation via cAMP/PKA
pathway reduces levels of pathological tau and rescues cognitive decline. Presently, symptomatic treatment
during the dementia stage cannot halt the disease progression. Therefore, identifying molecular mechanisms of
the earliest stages of tauopathy will help in the development of effective therapies against AD. The early
pathological hallmark of tauopathy disorders is abnormal missorting of tau into the somatodendritic
compartments of neurons. In synapses, accumulated tau is polyubiquitinated, implying a defect in proteasome-
mediated proteolysis, which can contribute to accelerated synaptotoxicity as proteasomes play an indispensable
role in maintaining synaptic plasticity and transmission. The Career Development Proposal’s AIM 1 will
investigate the effect of missorted synaptic tau on proteasome function in the pre and post -synaptic fractions.
One of the pathways related to synaptic plasticity is the cAMP/PKA pathway, which is regulated by the intra and
extra -cellular factors. AIM 2 will test the hypothesis that in AD, activity of PKA is downregulated as a
consequence of reduced synaptic proteasome proteolysis (the intra-synaptic factor), and depleted levels of
PACAP (pituitary adenylate cyclase–activating polypeptide) (the inter-synaptic factor). PACAP is an abundant
neuropeptide that when released from pre-synaptic compartments, binds and stimulate its receptor (PAC1R), a
GPCR subfamily receptor situated in the postsynaptic compartments which then leads to an increase in cAMP
production and PKA activation in dendrites. As a therapeutic strategy, AIM 3 will investigate if PACAP
administration restores PKA activity and activates proteasome function leading to tau clearance in dendrites and
improved synaptic function. Finally, AIM 4 will make use of robotic technology to develop a new screening assay
to test for proteasome activators and to assess if receptor-mediated proteolysis in synapses is applicable to other
subfamily GPCRs.
The data and insights generated during this award will identify a mechanism of post-synaptic proteasome
dysfunction that can contribute to synaptotoxicity by dysregulating the PKA pathway. Moreover, application of a
therapeutic strategy of receptor-stimulated proteolysis with spatially defined mechanism of action for effective
tau clearance can identify a new mechanism to halt missorting of tau and subsequent trans-synaptic spread.

Public health relevance
Neurofibrillary tangles are a feature of Alzheimer’s disease and several neurodegenerative diseases known collectively as the tauopathies. Although we do not know how tangles form, or exactly what type of tau causes the cell to become dysfunctional, it is likely that clearing abnormal, misfolded tau, especially at the early disease stage will attenuate disease progression and possibly cure, or stabilize the disease. Studies proposed here aim to understand better how missorted tau into dendrites causes proteasome dysfunction. The proposal’s objective is to use a novel therapeutic strategy to activate proteasome function only, or predominantly, in dendrites to clear missorted tau and improve synaptic function and develop a new assay that can be used to discover new molecules that activate clearance of misfolded proteins.